Novel Multi-Depth Two-Photon Microscope for Measuring Neuronal Network Plasticity

PROJECT SUMMARY Decades of studies in both human subjects and animal models indicate that the hippocampus is a critical brain structure involved in both the formation of memories and spatial navigation. Both of these computations are thought to create a cognitive map of features within our environment, which often contains dynamic sensory features that continuously change with time. However, it is not known if these seemingly separate computations within the hippocampus are interdependent, recruit common circuits, or utilize similar encoding strategies. In the parent R21 Trailblazer Award, we proposed to build a novel microscope that is capable of imaging neuronal activity in multiple hippocampal subfields simultaneously in order to ask how the hippocampus learns dynamic information by studying the formation of musical memories in mice. In the diversity supplement, the candidate Cristian Sharp plans to capitalize on this microscope technology to study the role of the hippocampus and its different subfields in navigation of spatial environments containing dynamic sensory information. Cristian’s goal is to become a neuroscientist, working on cutting edge neurotechnology and designing rigorous experiments to answer fundamental questions about brain function. As part of the current diversity supplement we have devised a detailed career development plan that will facilitate Cristian’s transition from the field of physics to biology and prepare him for graduate school in neuroscience by 1) working with an experienced multidisciplinary team of mentors, which include Drs. Matthew Shtrahman, Brenda Bloodgood, and David Kleinfeld; 2) following an individualized learning plan, mastering core concepts in biology through formal coursework; 3) performing hypothesis-focused biological research; 4) learning to communicate about his research through scientific lectures, manuscripts, and grant applications; 5) attending professional development courses and research conferences; and 6) preparing and submitting an NSF Graduate Research Fellowship application during the award period. With the support of the NIH diversity supplement and by achieving these career development milestones, Cristian will be well-poised for graduate school and his future research career in neuroscience.

Public health relevance
PROJECT NARATIVE In the current diversity supplement, the candidate Cristian Sharp will capitalize on new microscope technology developed in the parent grant to study the role of the hippocampus and its different subfields in navigation of spatial environments containing dynamic sensory information. As part of the diversity supplement, we have devised a detailed career development plan that will facilitate Cristian’s transition from the field of physics to neurobiology. With the support of the NIH diversity supplement and through the achievement of the career development milestones outlined in the proposal, Cristian will be well-poised for graduate school and his future research career in neuroscience.